Admin-Core

Administrative Core Module
Abstract
The overall goal of this UTSW Core Grant for Vision Research is to enhance the capabilities of vision research
scientists by facilitating easy access to equipment, training, and technical support, which will: 1) expand
experimental capabilities, 2) advance scientific rigor, 3) result in more cost-effective and time-efficient
research, and 4) open up new research directions. The Core Grant will also help to sustain a fertile
environment for the development of young vision researchers and expand the number of collaborative
research projects between investigators within UTSW, and between UTSW and other institutions.
Our proposed NEI Core Center consists of three Resource/Service Modules, each directed by faculty members
with experience and expertise in their unit’s focus area: 1) Stem Cell, Organoid and Cell Phenotyping; 2) Gene
Editing and Virus Production; and 3) Microscopy and Animal Phenotyping. W. Matthew Petroll, PhD, Principal
Investigator of the Administrative Core and Center Director, will be responsible for overall administration of the
Core Center and of the NEI P30 grant. Dr. Petroll will oversee Departmental staff who will provide
administrative support for Center activities. This will include: 1) arranging equipment maintenance, managing
service contracts, and purchasing supplies to support all three scientific Modules; 2) scheduling meetings
related to the Core Grant activities; and 3) maintaining budgets and providing monthly summaries of
expenditures to Dr. Petroll and the Module Directors. Dr. Petroll will hold monthly meetings with the Module
Directors to troubleshoot any problems that might arise, to ensure that priorities are met, and that Modules are
heavily used, and to identify opportunities for bringing new projects to the Center. He will also host the semi-
annual meetings of the Core Grant Advisory Committee, which will offer advice on technical issues and will
serve to adjudicate any serious conflicts that might arise. In addition, the Advisory Committee members have
strong connections to researchers in a variety of disciplines and are uniquely positioned to identify and
promote potential multi-disciplinary collaborations, as well as recommend the incorporation of new
technologies and techniques.
Success of the Core Grant will be assessed by the following outcome measures: a) number of participants
utilizing each Module; b) number of publications that benefited from one or more of the Modules; c) number of
pilot studies supported by the Core Grant that culminated in the awarding of new NEI research grants or
private foundation grants; d) number of postdoctoral fellows, medical students, and graduate students that
productively utilized each Module; and e) number of students whose dissertation research relied on the support
of one or more Modules and the number of these students who completed their PhD in an NEI-focused area.